Structural mechanisms of multimeric ATPases

Project Summary/Abstract
Structural mechanisms of multimeric ATPases
The Kelch Lab studies how multimeric ATPases drive the mechanics of biology. These
machines facilitate numerous biological pathways, ranging from DNA replication to virus
assembly. Despite their strong structural conservation, the mechanisms of multimeric ATPases
are varied, with some functioning as processive motors and others as molecular switches. How
this divergence in mechanism arises from conserved components remains unknown.
Here we investigate the structures and mechanisms of two similar ATPase machines that
demonstrate either processive or switch-like functions. The terminase is an exceptionally
powerful and processive motor that pumps DNA into viral capsids. Clamp loaders are ‘one-and-
done’ (non-processive) protein remodeling switches that open the sliding clamp ring and place it
onto DNA for replication and repair. Both of these machines are related pentameric ATPases
that assemble into ring-like structures, so the stark differences in function are not easily
explained by subunit stoichiometry or overall architecture.
The Kelch Lab has been at the forefront of elucidating the structural mechanisms of both clamp
loaders and terminases. We determined the molecular organization of the terminase motor,
which became the foundation for the past decade in the field. Our structures of clamp loaders in
action have provided unprecedented insight into the mechanism of the most conserved
components of the replication fork. In both terminases and clamp loaders, transitions between
spiral and planar conformations of the ATPase domains have been implicated, indicating that
motor or switch mechanisms are driven by similar structural changes. Not only have our studies
been impactful in their individual fields but, by comparing these two mechanisms, we have laid
the groundwork for understanding divergent ATPase mechanisms.
Our previous studies indicate that the differences in mechanism cannot be easily explained by
stoichiometry, overall architecture, or conformational changes of the ATPase domains, which
implicates timing and coordination of ATPase activity in determining function. Thus, we have
identified three open questions that are a prerequisite for understanding how Nature evolved
distinct ATPase functions:
- How do ATPase machines enforce directionality of the reaction?
- How do ATPases coordinate non-ATPase activities?
- How do exogenous factors modulate machine function?
To address these questions, we have developed a research program that combines structural
studies with incisive examination of biochemical activity and biological function. Furthermore, we
have assembled a team of collaborators whose expertise complements that of the Kelch Lab to
maximize the scope, breadth, and impact of our work. Our proposed studies will reveal the
mechanisms of two evolutionarily ancient and important machines, which will not only impact
the fields of DNA replication/repair and virus assembly but also ATPase biology in general.
There are numerous diseases associated with dysregulation of sliding clamps and clamp
loaders, and terminases are the target of FDA-approved drugs against viral pathogens.
Therefore, our studies have the potential to impact human health. More broadly, our studies lay
the groundwork for engineering ATPase nanomachines with novel activities or modes of
regulation.

Public health relevance
Project Narrative Sliding clamps are proteins that are critical to the copying of DNA. These ring-shaped proteins are installed or removed from DNA by clamp loaders. Sliding clamps and clamp loaders are important for cellular proliferation and cancer development. We will uncover how sliding clamps are put onto or removed from DNA in atomic detail. This work will provide an understanding of how nature’s nanomachines have evolved to do mechanical work, and will also provide a blueprint for how to target sliding clamp loaders for chemotherapy or antimicrobial therapy. The viral packaging motor is medically relevant in three separate ways: (1) This motor is the target of multiple drugs that combat herpesviruses that cause a variety of diseases, from STDs to cancer (for example, Burkitt’s Lymphoma, Kaposi’s Sarcoma, and Nasopharyngeal Carcinoma); (2 conformational) pathogenic bacteria use the motor to create ‘helper phage‘ to transfer pathogenicity islands, thus evolving more virulent and deadly strains of bacteria; (3) the motor is being engineered to create novel nanodevices that take advantage of its high speed and force generation for therapeutic delivery. Our studies will be critical in fulfilling the motor’s potential as both a drug target and as a drug delivery system.